Conference Grant to support American Psychosomatic Society's 78th and 79th Annual Scientific Meetings

For over 75 years, the American Psychosomatic Society has provided an outstanding forum for trainees and
established investigators and clinicians working within a wide range of disciplines and specialty areas to
exchange new ideas and research strategies, ultimately facilitating and improving the quality of research and
translation into clinical practice and public policy. Over 500 researchers and clinicians from around the world
attend the annual APS meeting. This R13 conference grant would provide support for pre- and post-doctoral
trainees to attend the 78th and 79th Annual Scientific Meeting of the American Psychosomatic Society (APS).
Previously supported by NHLBI for 12 years and NIA for 2 years, this R13 application requests support for up
to 5 Diversity Travel Awards and 15 Young Scholar Awards. APS Diversity Travel Award, continuously funded
by APS since 2007, will provide support for promising trainees from racial/ethnic or other underrepresented
groups to attend the annual meeting. The Young Scholars Award Program, continuously awarded since 1998,
will provide travel awards to competitively selected trainees who submit a first-author abstract to present a
paper or poster and who are judged to show outstanding potential for a career in psychosomatic and
behavioral medicine. As detailed in the Conference Plan, previous alums of these APS awards programs have
developed into successful scientists and clinicians; the majority have remained in academia, and all have
published in peer-review journals, with the majority publishing over 10 peer-review publications in their young
careers.
The APS annual meeting emphasizes research and training in biological, psychosocial, and behavioral
mechanisms of health and disease across the lifespan. Planned NIA-related scholar programming for the 2020
meeting includes training by Steven P. Wallace on the Resource Centers for Minority Aging Research
centers and fellowship opportunities. In 2021, Rebecca Thurston will provide training for scholars on the
Study of Women's Health Across the Nation (SWAN) Repository, with information on access and
highlighting the research findings from the study of mid-life, including ground-breaking work on cancer and
other diseases. With MDs and PhDs from around the world, and seven decades of history, there is no other
comparable scientific meeting that breaks down silos between medical specializations, psychology,
epidemiology, and public health quite like APS does, including in its training opportunities.

Public health relevance
Providing strong support and professional development to promising pre- and post-doctoral students is crucial for the advancement of all fields of science. This R13 application emphasizes research and training in biological, psychosocial, and behavioral mechanisms of health and disease across the lifespan. We propose to provide travel support for up to 20 trainees to attend the 78th and 79th Annual Scientific Meeting of the American Psychosomatic Society (APS).